Postsynaptic kinase/phosphatase networks in amyloid beta-induced synaptic dysfunction

Project Summary Abstract
Postsynaptic kinase/phosphatase networks in amyloid β-induced synaptic dysfunction
Alzheimer's disease (AD) is characterized by impaired synaptic function and synapse loss in key
forebrain areas required for learning and memory, including the hippocampus. While the pathologic agent that
causes AD remains contentious (amyloid-beta; Aβ vs. tau) there is strong genetic, biochemical, anatomical and
electrophysiological evidence supporting that Aβ is sufficient to initiate cellular processes leading to severe
synaptic pathology. For example sub-micromolar doses of Aβ acutely (within minutes) inhibit long-term
potentiation (LTP), a form of synaptic plasticity critical for learning and memory. In addition, longer Aβ
exposure (days to weeks) leads to depression and elimination of excitatory synapses through a
process that requires NMDA receptor signaling. However, the downstream signaling networks that drive
acute and chronic Aβ-mediated synaptic pathologies are only beginning to emerge and need to be further
investigated. Strong preliminary data from our labs implicate several postsynaptic ser/thr kinases (CaMKII,
DAPK1, PKA) and a phosphatase (calcineurin (CaN)) as key molecular players responsible for acute Aβ-
induced LTP disruption, possibly through impaired NMDA receptor Ca2+ entry. It remains unclear whether
these same signaling mechanisms mediate chronic Aβ-induced synaptic depression and elimination, but
published and preliminary data presented here indicate that CaN activity is required. Importantly, all of these
kinases and phosphatases interact with one another in a postsynaptic signaling network that integrates
NMDAR activity to promote either LTP or LTD. Indeed, synaptic anchoring of PKA and CaN by the scaffold
protein AKAP79/150 appears to be critical for promoting signaling crosstalk between PKA, CaN, DAPK1 and
CaMKII at synaptic sites to establish normal LTP/LTD balance. In this multi-PI project we will test the
hypothesis that Aβ causes acute (Aims 1 & 2) and chronic (Aims 3 & 4) synaptic dysfunction by perturbing the
balance of this signaling network and its downstream effectors to favor LTD, leading to impaired LTP and
synapse elimination.

Public health relevance
Project Narrative Postsynaptic kinase/phosphatase networks in amyloid β-induced synaptic dysfunction In Alzheimer's disease (AD) overproduction of amyloid beta (Aβ) protein fragments from the amyloid precursor protein (APP) is thought to interfere with the normal signaling functions of brain synapses during aging to interfere with learning and memory and cause dementia. Elucidating how Aβ interferes with synaptic function is an important first step for understanding the mechanisms underlying cognitive impairments associated with AD and could result in the identification of novel drug targets and therapies. However, very little research to date has shed any light on the mechanisms by which Aβ engages and interacts with specific synaptic signaling pathways to cause neuronal dysfunction and cognitive impairment. Here, with the use of an innovative genetically engineered mouse model, we will test the novel idea that Aβ activates signaling that impairs synaptic and cognitive function through a protein called Calcineurin that is specifically anchored at synapses by a protein called AKAP150. Importantly, these studies will investigate whether targeted disruption of AKAP150-anchored Calcineurin signaling at synapses and/or interfering with some of its downstream targets could be worth exploring as a viable therapy for preventing synaptic and cognitive dysfunction in AD.